Equity and Dissemination Core

EQUITY AND DISSEMINATION CORE SUMMARY
The purpose of the Equity and Dissemination (E&D) Core is to maximize the impact of the Improving causal
inference in AD projects for prevention research on modifiable risk factors: the Triangulation of
Innovative Methods to End AD (TIME-AD) project on improving health equity and population health. The
E&D Core will accomplish this foremost by continually focusing on health equity while collaborating with
projects and cores throughout the analytic and dissemination stages to produce unbiased, culturally-relevant
scientific findings. This core will seek opportunities for more inclusive data analysis approaches, such as
settings where more representative data might be incorporated or added to enrich the diversity of study
findings, and opportunities for analytics that would extend findings from non-representative samples to more
diverse populations. Once TIME-AD scientists have produced unbiased findings relevant to these
subpopulations, the core will disseminate results to relevant stakeholders who can use and act on the evidence
in an inclusive manner. This includes identifying components of our work that should be shared with different
target audiences, including researchers, the general public, clinical providers and health systems, community
health advocates, media sources, or policymakers. This core responds to a well-recognized need to reduce
AD/ADRD inequities and will ensure that TIME-AD projects findings are relevant to this aim and that they reach
real-world stakeholders in the most impactful form.